CE25-029 - Pathways Between Child Maltreatment and Self-Directed Violence: A Longitudinal, Population-Based Study Using Machine Learning Approaches

This K01 award application is for Dr. Lindsey Palmer, a PhD-trained social worker whose overarching career
goal is to become an independent violence prevention scientist, focused on promoting child health and well-
being by advancing data-driven, evidence-based strategies to prevent maltreatment and its long-term
consequences. This K01 will support three key areas of career development: 1) the application of machine
learning approaches on violence prevention research, 2) cross-cutting violence prevention strategies, and 3)
professional development and leadership. Dr. Palmer has assembled an interdisciplinary mentoring team
comprised of Kristine Campbell, MD, MSc, a nationally recognized expert in pediatric child maltreatment with
extensive experience collaborating with public agencies to develop cross-system prevention efforts; Fernando
Wilson, PhD, an expert in the application of machine learning techniques on large-scale databases to examine
health services and policy; Brooks Keeshin, MD, an internationally recognized expert in trauma assessment
and suicide prevention; and Angela Fagerlin, PhD an expert in faculty enhancement, leadership and
representation. Over the past decade, rates of self-directed violence (SDV) have risen sharply, particularly
among 10- to 17-year-olds, with children and adolescents who have experienced maltreatment being at
particularly heightened risk. A staggering 57% of children and adolescents who die by SDV have a history of
alleged child maltreatment, which encompasses physical abuse, sexual abuse, emotional abuse, physical
neglect, and exposure to intimate partner violence. These youths often face the compounded challenges of
trauma, family dysfunction, and mental health issues. While child welfare system (CWS) involvement
frequently signals heightened vulnerability, the pathways linking child maltreatment to SDV remain poorly
understood. Contributing factors such as parental mental illness, substance use, overlapping forms of
maltreatment, family instability are not well defined or understood. Additionally, there is limited evidence on the
effectiveness of CWS interventions in reducing the risk of SDV for these children. This study’s Specific Aims
include: 1) Determine the relationship between child maltreatment and SDV, specifically: Establish how the
timing, type, and frequency of child maltreatment indicators are associated with SDV; and characterize the
association between child maltreatment intervention and SDV; and 2) Leverage machine learning based
approaches to identify direct and indirect pathways between child maltreatment and SDV, focusing on the
progression of suicidal thoughts and behaviors over time. This study is significant and innovative because it will
clarify the relationship between child maltreatment and SDV, identify high-risk subgroups, and examine if
existing CWS interventions mitigate or exacerbate SDV risk, providing critical insights into the strengths and
limitations of current maltreatment practices in reducing other forms of violence.

Public health relevance
This project aims to investigate the relationship between child maltreatment and self-directed violence among children and adolescents. By leveraging linked population-level administrative data from child welfare records, medical records, and vital statistics, the research will explore how different types of maltreatment and child welfare interventions contribute to SDV risk. I will also engage in career development and training activities that will enhance my expertise in using large-scale longitudinal birth cohorts by learning and applying machine learning approaches and cross-cutting violence prevention strategies to investigate interpersonal violence amongst children.